Administrative Core

Core A of the Program Project will reside in the Department of Physiology and Biophysics of the Albert Einstein College of Medicine which is the academic home of the Principal Investigator, Joel Friedman and the applicant institution. The chairman of the Department, Professor Denis Rousseau, is fully supportive of this program and will also be a member of the Internal Advisory Board. Albert Einstein College of Medicine is headed by the Dean, Professor Alan Spiegel. The Dean is also very supportive of the program and has committed additional funds for instruments in the event the PPG is funded (see attached letter). The administrative office of Core A consists of three components: i) The Pi's office; ii) a small adjacent office for the administrative secretary; and iii) the administrative office of the Pi's department (Physiology and Biophysics) which is located on the same floor and doors down from the Pi's office.